Parallel maturation of social behaviors and amygdala circuits

Adolescence is a critical window for social maturation. Harmful experiences during adolescence can
produce life-long social impairments, partly by impacting key brain regions involved in social function, such
as the amygdala. The long-term goal of our research is to understand how experience during development
shapes the amygdala and its connections, and how their dysfunction produces social impairments. Social
motivation drives engagement in social behaviors, but there is a homeostatic balance that is sensitive to
social deprivation and satiety, and social behaviors need to reflect this balance. In our prior project period,
we found that medial amygdala (MeA) and basolateral amygdala (BLA) have complementary roles in social
behaviors and different sensitivities to factors that temper social motivation. We also demonstrated
differences between adult and adolescent social motivation, and their sensitivity to social change. But there
is a gap in our understanding of the synaptic and molecular changes that adjust social motivation over short
behavioral timescales and larger timescales between adolescence and adulthood. The prefrontal cortex
(PFC) sends excitatory glutamatergic projections to BLA, matures during adolescence, and has a key role in
regulation of many social behaviors. Our short-term goal is to uncover the synaptic and microcircuit
changes at the PFC-BLA interface that regulate social motivation, and how this matures during
adolescence. Fast glutamatergic synaptic responses in the BLA are predominantly driven by AMPA
receptors (AMPAR), whose impact depends on the subunit composition. Based on the prior project period
and preliminary data, we propose that there are functional shifts in relative AMPAR subunit composition at
PFC-BLA synapses to BLA output neurons, and to BLA GABAergic interneurons that regulate output
neurons. These contribute to a shift in social motivation during adolescence, and to rapid shifts during social
deprivation and satiety. We will test the hypotheses that during transition from adolescence to adulthood
there is a functional redistribution of AMPAR subunits so that PFC glutamatergic inputs to BLA GABAergic
interneurons gain relative strength compared to BLA output neurons, and changes in social motivation
rapidly change AMPAR subunit composition at PFC-BLA synapses to permit an appropriate adaptation in
social behavior. The Aims of this project are to determine (1) cellular and synaptic elements in BLA that
contribute to emergence of a mature PFC-BLA impact, (2) the role of AMPAR at PFC-BLA synapses in
adapting to social motivation changes, and (3) the functional impact of PFC inputs on BLA encoding of
social cues during changes in social motivation. This project is significant because it will delineate a
synaptic mechanism for modulation of social motivation, and how this matures into adulthood. This will yield
exciting new perspectives about parallel development of social regulation and PFC-BLA circuits, and is an
important step towards understanding how dysfunctional PFC-BLA circuits cause social impairments.

Public health relevance
Project Narrative Impairments of social function and their underlying brain circuits are common to multiple psychiatric disorders. Adolescence is a sensitive period for social and neural development that often coincides with the emergence of psychiatric disorders. We need to learn more about the synaptic and molecular substrates that promote the function and maturation of social brain circuits to understand the pathophysiology of impaired social function.